A Novel Mechanism of Immune Escape by B-cell Lymphoma

Abstract
Hematological malignancy is noted as a presumptive disease related to ionizing radiation exposure during
military service and has been associated with exposure to toxic contaminants. Lymphoid malignancies such
as lymphoma and leukemia often compromise host defense by developing mechanisms to evade immune
surveillance. Effective tumor immune responses involve the activation and maintenance of tumor-specific
CD8+ HLA class I-restricted cytotoxic T cells (CTL) and tumor-specific CD4+ class II-restricted helper T cells.
However, many B-cell lymphomas cannot optimally present antigens (Ags) via the HLA class I pathway, which
contributes to their escaping immune recognition from tumor-specific CD8+ T cells. We have recently shown
that B-cell lymphoma-induced stimulation of CD4+ T cells is also impaired however, the mechanisms involved
remain unknown. Preliminary and published data presented here indicate that B-cell lymphomas shed a
49kDa Fc Receptor Like A (FCRLA) molecule which suppresses the ability of professional antigen presenting
cells (APCs) to stimulate CD4+ T cells via the HLA class II pathway. We hypothesize that the shedding of
this FCRLA molecule plays a key role in B-cell lymphoma-mediated immune suppression and that
blockade of this molecule may restore T cell recognition of this class of malignancies. In support, we
show that a novel 49kDa FCRLA molecule secreted by B-cell tumors binds to HLA class II protein and disrupts
functional Ag presentation by professional APCs. Second, higher levels of FCRLA were detected in B-cell
lymphoma patients, which correlated with poor patient outcome. Third, knockdown of FCRLA by shRNA
restored functional HLA class II-Ag presentation by B-cell lymphomas to T cells. Fourth, FCRLA antibody
therapy augmented CD4+ T cell recognition of B-cell lymphoma in vitro and in vivo. These data provide a solid
foundation for our overall goal of elucidating the inhibitory mechanisms of a novel 49kDa FCRLA protein on
HLA class II-mediated T cell recognition of B-cell lymphomas. Studies are also planned to determine the
extent to which immune recognition can be restored by blocking FCRLA functions in vivo. Studies are also
planned to determine whether FCRLA blocking antibody augments immune recognition of B-cell lymphomas.
To accomplish the goals of the proposal, two specific aims are proposed: (Aim 1) To elucidate the molecular
mechanisms through which FCRLA disrupts HLA class II-peptide interactions and impairs T-cell recognition.
To accomplish this aim, we will test the hypothesis that B-cell lymphoma-derived 49kDa FCRLA protein
disrupts peptide binding to HLA class II and impairs CD4+ T cell recognition of tumors. (Aim 2) To investigate
the efficacy of FCRLA blockade in enhancing T cell recognition of B-cell lymphomas in vivo. To accomplish
this aim, we will test the hypothesis that B-cell lymphoma-shed 49kDa FCRLA may influence tumor growth in
vivo, and that blockade of FCRLA will augment antitumor immunity in the host. Blockade of FCLRA function
may have the potential to drastically alter lymphoma progression in vivo. Completion of these studies will
elucidate novel mechanisms for restoring Ag presentation in lymphoid malignancy, and the elucidated
mechanism will likely spur development of novel therapeutic strategies for B-cell lymphomas that may be
applicable to other malignancies. Since lymphoma accounts for almost 4% of all cancer diagnoses in the
Veterans, the success of this project will also profoundly improve the treatment and survivorship of veterans
and their family members who developed lymphoma.

Public health relevance
Narrative: This proposal will investigate the role of a novel lymphoma-shed 49kDa Fc receptor like A (FCRLA) molecule in HLA class II-mediated immune disruption of human B-cell lymphomas. The goal of this proposal is to dissect the mechanisms of FCRLA-mediated inhibition of class II-restricted CD4+ T cell recognition of B-cell lymphomas in vitro and in vivo by employing genetically manipulated lymphoma cells, antigen-specific T cells, and FCRLA blocking antibody. The proposed study will determine whether FCRLA shedding plays a significant role in modulating the activity of CD4+ T cells, and if blocking of FCRLA augments antitumor immunity. Overall, these studies will elucidate novel mechanisms for restoring immune detection of lymphoid malignancy, which will likely spur development of novel therapeutic strategies for B-cell lymphomas that may be applicable to other malignancies. The success of this project will also profoundly improve the treatment and survivorship of Veterans and their family members.